RADIATION ONCOLOGY RESEARCH AND CLINICAL CENTER

The overall objective of this program project is to explore and improve the utilization of radiation and combinations of radiation and other modalities in order to increase the cure of cancer and to evaluate the long term effects of radiation and combinations of radiation and other modalities. These objectives will be achieved by: a. Continuing the development of a specialized Radiation Oncology Research and Clinical Program Project. This Project will continue to develop an overall integrated program for research in radiation biology, radiation immunology, radiation physics and related basic sciences and to promote, enhance and stimulate the investigation of the basic mechanisms of radiation, and combination of radiation and other agents in the treatment and control of cancer and evaluation of long term effect with the goal of possible human application in mind. b. Continuing to expand our overall integrated program to carry out clinical research utilizing radiation combined with other agents to improve results in the treatment of human cancer and to integrate information obtained from basic research whenever possible to the clinical treatment. c. Continuing to provide a center for demonstration and teaching of the appropriate advanced therapeutic methods and techniques so that these can be taught to physicians, medical students, and support personnel of this area and thus be made available to patients. d. Continuing to provide and further develop our Training Program in radiation oncology for graduate and undergrade physicians, technicians and nurses for this region.